Structures and Activities of Prions and Prion Proteins

Understanding the structure of PrPSc and its strain variation has been one of the major challenges in prion disease biology. To study the strain-dependent conformations of PrPSc, we purified proteinase-resistant PrPSc (PrPRES) from mouse brains with three different murine-adapted scrapie strains (Chandler, 22L, and Me7) and systematically tested the accessibility of epitopes of a wide range of anti-PrP and anti-PrPSc-specific antibodies by indirect-ELISA. We found that epitopes of most anti-PrP antibodies were hidden in the folded structure of PrPRES even though these epitopes are revealed with guanidine-denaturation. However, reactivities to a PrPSc-specific conformational C-terminal antibody showed significant differences among the three different prion strains. Our results provide evidence for strain-dependent conformational variation near the C-termini of molecules within PrPSc multimers.